Neuropeptidergic regulation of valence processing underlying the sex differences in AUD

PROJECT SUMMARY
Alcohol use disorder (AUD) is one of the most prevalent mental disorders worldwide. Compared to men,
women not only suffer from greater alcohol intoxication and withdrawal effects but also develop AUD more
rapidly. It suggests that women may be particularly susceptible to the negative valence induced by alcohol
withdrawal, which leads to escalated alcohol drinking. However, how valence processing is differentially
affected by chronic alcohol drinking between males and females and contributes to the sex differences in the
development of AUD is still unknown. A key brain region implicated in valence processing that is dysregulated
by alcohol is the bed nucleus of stria terminalis (BNST). Studies show that the BNST exhibits significant sexual
dimorphism and is essential for encoding the positive and negative properties of alcohol. In addition, BNST
neural activity can be modulated by neuromodulatory actions of neurotensin (NT), a 13 amino acids
neuropeptide differentially regulated by sex hormones. Studies have shown that NT enhances inhibitory inputs
to BNST neurons and mediates anxiety-like behavior via postsynaptic NT receptor type 1 (NTSR1) and that NT
gene expression is correlated with alcohol consumption in women. Together, these findings suggest a sex-
dependent NTergic modulation of the BNST on negative affect states during alcohol drinking. We will test the
central hypothesis that NTergic modulation mediates the sex difference in alcohol drinking by selectively
enhancing BNST encoding of negative valence during acute withdrawal via NTSR1. Aim 1: We will test
whether acute alcohol withdrawal enhances BNST encoding of negative valence in females via NTSR1. We
will record BNST glutamatergic and GABAergic neurons using in vivo electrophysiology and optogenetic photo
tagging in a valence discrimination task before and weekly during the withdrawal periods of intermittent access
(IA) alcohol drinking paradigm in both sexes of mice with and without Cre-dependent CRISPR-Cas9
knockdown of Ntsr1 in the BNST. Aim 2: We will examine whether NTSR1 signaling in the BNST drives the
escalated alcohol drinking in females by pharmacologically or genetically inhibiting BNST NTSR1 at different
stages of the IA paradigm or in glutamatergic and GABAergic neurons of both sexes. Aim 3: We will dissect
the NT sources that regulate BNST NT dynamics during valence processing and alcohol drinking. We will
measure BNST NT dynamics to motivational valence during a valence discrimination task before and weekly
during IA alcohol drinking in both sexes with and without optogenetic inhibition of NTergic inputs to the BNST.
We will also examine whether Nts CRISPR knockdown in these projections before IA alcohol drinking affects
alcohol drinking of both sexes. Successful completion of this proposal will reveal the functional architecture of
NT in mediating dysregulated valence processing in the BNST by IA alcohol drinking and provide critical
knowledge of neuropeptidergic modulations in sex differences in AUD.

Public health relevance
PROJECT NARRATIVE This project aims to explore how neuromodulation, specifically neurotensin, plays a critical role in sex differences in valence processing during alcohol drinking in the bed nucleus of stria terminalis (BNST), a site identified as a divergence point in circuits mediating positive and negative valence and alcohol drinking. This project will test the hypotheses that NT release promotes BNST neural encoding of negative valence in a sex- dependent manner and mediates the escalated alcohol drinking in females via NT receptor signaling. The proposed research project will broaden our understanding of the fundamental neuromodulatory mechanisms underlying valence processing and sex differences in alcohol drinking and identify neurotensin as a novel target for treating alcohol use disorders.